Genetics of Coxiella burnetii

Coxiella burnetii is an obligate intracellular bacterium and the causative agent of the zoonosis human Q (query) fever. Acute Q fever normally manifests as a self-limiting influenza-like illness. Rare but serious chronic infections can occur that usually present as endocarditis or hepatitis. The vast majority of human Q fever cases are acquired through contact with infected domestic livestock where the organism can be endemic. C. burnetii can chronically infect a variety of animals and is shed in large numbers in various secretions and products of parturition. Adding to the insidious nature of the organism is an infective dose approaching one organism and a remarkable extracellular stability approaching that of a bacterial spore. Environmental resistance also correlates with resistance to the degradative conditions of a phagolysosome-like parasitophorous vacuole (PV), Coxiella's niche within host macrophages. The impressive environmental stability of C. burnetii is likely due to the biogenesis of a highly resistant cell form termed the small cell variant (SCV). This form arises during a biphasic developmental cycle and is likely responsible for the majority of environmentally acquired cases of Q fever. Once internalized and sequestered in a PV, SCV morphologically differentiate into more metabolically and replicatively active large cell variants (LCV). Mature PV contain a mixture of SCV, LCV and intermediate forms. The molecular biology of C. burnetii morphological differentiation is poorly understood. An important area of future research includes defining the transcriptional capabilities of cell forms and the response of C. burnetii to lysosomal stress. Restriction fragment-length polymorphism analysis reveals considerable genomic DNA heterogeneity among C. burnetii strains. Moreover, strains can be grouped according to association with human acute or chronic disease, suggesting groups have unique virulence potential. Although the severity of disease and the potential for chronicity may involve patient factors, there is a clear association of C. burnetii isolates with disease outcome. The extent and biological relevance of strain variation is unknown. Strains of lower virulence may result in subclinical infections where diagnosis and treatment are delayed, resulting in chronic infections with serious consequences years or decades later. A distinct genomic group is represented by acute disease isolates similar to the Nine Mile prototype, while chronic isolates and isolates from goat and sheep abortions have been organized into additional groups. All isolates carry an endogenous plasmid (~36-39 kb) or integrated plasmid-like sequences. The association of acute/chronic disease isolates with specific genomic groups has led to the hypothesis that isolates may harbor unique genetic determinants that confer distinct pathogenic potential. Elucidation of the genome sequences of chronic endocarditis isolates, and comparison to the deciphered genome of the Nine Mile isolate, will provide a more complete understanding of the genome architecture and genetic diversity of C. burnetii, thereby improving our ability to model Coxiella pathogenesis. Genetic diversity of C. burnetii is also revealed by production of antigenically and structurally unique lipopolysaccharide (LPS) molecules. LPS is the only defined virulence factor of C. burentii. Distinct C. burnetii LPS chemotypes have been described that are associated with specific genomic groups and a potential link between LPS chemotype and C. burnetii virulence potential has been proposed. Virulent C. burnetii isolated from natural sources and infections all produce a full-length LPS that is serologically defined as “phase I”. Serial in vitro passage of phase I C. burnetii in embryonated eggs or tissue culture results in decreasing molecular weight LPS molecules, culminating in the severely truncated LPS of avirulent phase II organisms. Phase II LPS contains lipid A and some core sugars, but is missing O-antigen sugars, and appears to represent the minimal LPS structure of C. burnetii . The precise genetic mechanisms of C. burnetii phase variation are unknown. Genetic systems such as complementation, transposon mutagenesis, and allelic exchange are invaluable tools in the study of bacterial virulence. These methods require the introduction of foreign DNA into the bacterial recipient usually via electroporation. Genetic transformation) generally requires strong selectable markers in the form of antibiotic resistance genes. While genetic transformation has been described for C. burnetii, the system is hampered by inadequate antibiotic selection, instability of introduced DNA, and the lack of efficient cloning methods for clonal isolation. There are currently no vaccines licensed for use in the US to protect against Q fever. Experimental vaccines and vaccines licensed in other countries are generally comprised of inactivated whole-cell C. burnetii. Although efficacious, these vaccines suffer in being highly reactrogenic in sensitized individuals, thereby necessitating extensive pre-vaccination screening. Protective subunit vaccines are needed.